Mechanisms of DNMT3B-mediated DNA Methylation Maintenance

PROJECT SUMMARY
DNA methylation (5mC) is catalyzed by three DNA methyltransferases (DNMTs): DNMT1, DNMT3A, and
DNMT3B. DNMT3A and 3B are often referred to as de novo DNMTs, functioning to establish 5mC patterns
during early embryonic development. DNMT1 is referred to as the maintenance methyltransferase, functioning
to copy established 5mC patterns on newly replicated DNA in differentiated and self-renewing stem cells.
Despite this simplified division of labor, DNMT3A and 3B also contribute to 5mC maintenance, though the
regulatory mechanisms involved are incompletely understood. A key 5mC regulatory mechanism is the
interaction between DNMTs and histone post-translational modifications (PTMs). For example, lysine
methylation on H3K4 and H3K36 has been reported to repel or recruit DNMT3B binding, respectively. The
functional outcomes of these interactions aid in the regulation of gene expression and transcription fidelity.
Specifically, DNMT3B-mediated methylation of actively transcribed gene bodies was shown to protect against
spurious transcription, and this function is dependent on tri-methylation of H3K36 (H3K36me3). However, my
preliminary data, as well as data from prior literature, show that H3K36me3 is dispensable for gene body 5mC
maintenance. These results challenge the established model and suggest that there are alternative
mechanisms which regulate DNMT3B-mediated 5mC at intragenic regions. The overarching goal of this
fellowship proposal is to define mechanisms of DNMT3B recruitment and activity in gene bodies of embryonic
and differentiated cells. In addition to histone H3, DNMT3B was reported to directly interact with the
transcription elongation-associated hPAF1C complex in embryonic development. Further, hPAF1C
components are required for deposition of H3K36me3 across gene bodies, and hPAF1C mutation results in
aberrant expression of genes silenced by DNA hypermethylation. Taken together, these data lead me to
hypothesize that DNMT3B is recruited to chromatin through multivalent engagement of the N-terminus of
histone H3 and hPAF1C to establish and maintain gene body 5mC. This hypothesis will be tested with two
Specific Aims. In Aim 1, I will utilize oncohistone mutations, CRISPR/Cas9 genome editing, and genetic
complementation experiments to rigorously define the contribution of H3K4 and H3K36 methylation in the
regulation of DNMT3B-mediated 5mC maintenance. Additionally, I will use publicly available cancer genome
data to understand the clinical relevance of DNMT3B- mediated gene body 5mC. In Aim 2, I will use chemical
inhibitors of transcription elongation, protein-protein interaction analysis, and deep RNA-sequencing to
investigate the interaction between DNMT3B and hPAF1C and its role in co-transcriptional deposition of 5mC
in gene bodies. Collectively, these studies will lead to a deeper understanding of mechanisms of epigenetic
and transcriptional crosstalk that contribute to the propagation of aberrant 5mC patterning in human cancers.

Public health relevance
PROJECT NARRATIVE Aberrant DNA methylation patterning is a hallmark of cancer. Additionally, DNMT3B mutations cause Immunodeficiency, Centromere instability, and Facial anomalies syndrome (ICF). This study seeks to define the regulatory mechanisms of DNMT3B-mediated DNA methylation maintenance in order to provide insight into cancer etiology and eventually aid in the development of targeted treatments for many different cancer types as well as ICF.